Pilot Projects

The CURES Pilot Project Program (PPP) is intended to provide both initial support to early stage and new
investigators to enable them to establish their environmental health research programs and supplemental
support to established investigators to enable them to pursue innovative new ideas that broaden or depart from
their existing research programs. The PPP also serves to encourage investigators in different disciplines to
apply their research expertise to environmental health problems, thereby broadening the knowledge and skill
base of CURES. Additional goals of the PPP are to provide an effective mechanism for attracting new
members to CURES and to promote career enhancement, especially of early stage and new investigators. The
PPP is an essential component of the CURES process for building its capacity to enhance our understanding
of the adverse health effects from chemical and nonchemical urban environmental exposures; develop the next
generation of environmental health researchers who are facile with transdisciplinary, translational team
science; and interact with the community so as to leverage our research to improve the health of the people of
Detroit. The specific aims of the PPP are: 1) Administer the PPP by a) planning each year’s funding
opportunity, advertising the availability of pilot grants, providing guidance to potential applicants, and
coordinating the submission and review of applications, b) awarding 3-7 new pilot grants each year of the
funding cycle, with each award for $60,000 over a 1.5-year period, c) monitoring pilot projects during the pre-
award, award-time, and post-award phases, and d) tracking success of the PPP by recording all efforts to
secure extramural funding, all publications and presentations of research findings resulting from the pilot
project, successful career advancement of pilot project recipients, and evidence of scientific impact of the
projects, as well as their impact on the community and on research translation. 2) In collaboration with the
Career Enhancement Program, use the PPP as a mechanism to support the career enhancement of early-
stage and new investigators. 3) In collaboration with the Community Engagement Core (CEC) and its
Community Advisory Board (CAB), provide a mechanism for community engagement by a) seeking input from
CAB members about their environmental health concerns before developing annual requests for applications,
b) providing our CAB with a say in determining which pilot projects are funded by having CAB members review
LOIs to assess how well prospective projects address environmental health issues of concern to the
community, c) increasing our CAB’s capacity to review, as well as their knowledge about the EHS research
that is conducted by CURES, by including new “shadow reviewers” in each year’s LOI review process and
providing tutorials on how to review research proposals, and d) requiring pilot project recipients to present their
research at CEC-sponsored events, such as CAB meetings and environmental health forums (EH Chats).